Bioinformatics for Next Generation Sequencing

The TCI Bioinformatics for Next Generation Sequencing Shared Resource (BiNGSSR) provides NGS focused computational analyses for cancer investigators and clinicians. The mission is to advise on experimental design and protocols related to NGS technologies, provide a broad range of bioinformatics analyses for multiple applications spanning bulk and single cell epigenomics, transcriptomics and genomics, perform data integration and visualization, and assist in cancer focused data interpretation. BiNGSSR furthers scientific discoveries by establishing robust computational pipelines for analyzing NGS data for TCI members and offers extensive training platforms for the Mount Sinai and global research communities. BiNGSSR is also dedicated to creating opportunities to increase the STEM pipeline. The Specific Aims of this Shared Resource are to: (1) Provide comprehensive NGS data analysis services; (2) Evaluate, interrogate, and implement new data analysis pipelines and new data analysis types to enhance data rigor and access.